MMP responsive polymeric materials for treating acute myocardial infarction

Summary
Heart failure (HF) remains the leading cause of death in the U.S., and the rest of the western world.
Approximately 37% of myocardial infarction (MI) patients will die from HF within 1 year, and of those who do
survive, two-thirds do not make a complete recovery. Each year it is estimated that ~550K Americans will have
a new MI, and ~200K will have a recurrent MI, leading to a large body of patients suffering from HF.1 Therefore,
our long-term goal is the development of new, minimally invasive, targeted biomaterial based therapies for the
treatment of acute MI (AMI), thereby limiting the number of patients that progress to HF. Over the past two
decades, there has been significant progress in the development injectable biomaterials that stimulate
endogenous repair on their own or through the controlled release of additional therapeutics. This approach is
attractive since potential therapies could be delivered minimally invasively via catheter, would be off the shelf
and cost-effective, and in the case of therapeutic delivery, would provide targeted delivery limiting systemic off-
target effects that plague traditional pharmaceuticals. However, direct injection of these biomaterials, either
through minimally invasive surgery or percutaneous transendocardial injection, is unlikely to be translated to AMI
patients because of serious safety concerns with the injection procedures, thereby missing the critical therapeutic
window immediately post-MI. Together, the PIs developed enzyme-responsive, injectable nanoparticles (NPs),
capable of responding to matrix metalloproteinases (MMPs) associated with AMI. The particles accumulate
efficiently in infarcted myocardium following systemic administration, by virtue of an enzyme-induced phase
transition from small NP to micron-sized scaffold. While we had initial success with this system and observed
better targeting compared to traditional modalities, this system suffers the same drawback as most nanoparticles,
which have significant off-target accumulation, as they are phagocytosed and transported to the liver following
opsonization. Leveraging our success with the general MMP responsive targeting strategy, we propose that a
new MMP responsive material comprised of a completely aqueous soluble polymer displaying therapeutic
peptides at high densities will have superior biodistribution patterns nanoparticles. Upon systemic administration,
these polymers exhibit exceptionally favorable pharmacokinetics (week-long half-lives) and biodistribution
characterized by kidney clearance combined with very little liver/spleen accumulation. These polymers are
protein like in molecular weight (MW), physicochemical properties and size. They are therapeutic proteomimetic
polymers, designed to accumulate at the site of AMI. Here, we aim to develop new MMP responsive polymeric
systems (termed protein-like polymers, PLPs) and demonstrate proof-of-concept for using these novel
biomaterials for the targeted delivery of therapeutics for AMI.

Public health relevance
Project Narrative The development of alternative therapies for myocardial infarction is a necessity because of the large patient population. Innovative new approaches are needed, capable of application immediately following heart attack, to control deleterious processes leading to poor cardiac function following initial survival. This proposal seeks to develop new biomaterial based therapeutic platforms for treating acute myocardial infarction.